Core 2. Visual Function and Non-invasive Ocular Imaging Core (VFNOIC)

Summary
The Visual Function and Non-invasive Ocular Imaging Core will provide expert technical support and equipment
for the analysis of visual function and ocular structure in vivo. The Core will provide equipment for the analysis
of the visual function in living mice and the ocular tissues in the posterior and anterior sections of the eye, train
laboratory personnel in experimental protocols, provide technical assistance and specialized analysis of ocular
tissue in vivo using 2-photon microscopy, and maintain existing instrumentation.

Public health relevance
Project Narrative Not require per FOA.